Pharmacological and Behavioral Indices of Drug Abuse

bythe time of award PHS 398 (Rev 05/01) Page 3 RCA Substitute Form Page 3 Number pages consecutively at the bottom throughout the application Do not use suffixes such as 3a 3b [] []